Spectral Cell Sorter

The Tufts Laser Cytometry (TLC) Core Facility is applying for funds to purchase a Bigfoot Spectral Cell Sorter
(ThermoFisher Scientific). This instrument will be a critical acquisition, allowing TLC to maintain its mission of
providing high-quality and up-to-date flow cytometry services to the research community within the extended
Tufts University campus network.
TLC was established in 1998 and has continued its status as the only Flow Cytometry Core facility at Tufts
University ever since. TLC is an indispensable service provider to the science community. Its success in
supporting high-impact NIH-funded research can be largely attributed to its outstanding and dedicated staff
members, Mr. Allen Parmelee and Mr. Stephen Kwok, as well as the continuous institutional (financial)
support. In the past two years, 53 laboratories used the Core's sorting service. The majority of them are NIH-
funded, with several others actively seeking initial or renewed NIH funding. Researchers that rely on the TLC
work in health- and life-sciences disciplines including immunology, microbiology & host-pathogen interaction,
cellular & cancer biology, genetic & associated diseases, neurobiology & neurologic diseases, developmental
biology, and aging.
TLC currently offers its services via two suites of instrumentation. The Analytic instrument suite includes a
FACSCalibur and an LSRII (both BD), along with a new Aurora Spectral Flow Cytometer (Cytek). The Sorter
instrument suite includes a MoFlo, a legacy Influx with biosafety containment (both 15+ yrs old), and a Cytek
customized BD FACSAria II (Cytek-Aria, 10+ yrs). The suite of Sorter instruments is outdated and increasingly
unreliable. By the end of 2021, none of the current sorters in TLC will be serviceable by their vendors. To
prevent interrupting the critical sorting service to NIH-funded users, a new cell sorter will be essential. The TLC
team considered the current and anticipated needs of its users and both of our Suite' capabilities and
determined that the Bigfoot Sorter is the only logical choice. Part of the decision-making process pivots on
harmonizing the capabilities of Analytic and Sorter equipment already in the facility. For instance, the current
Cytek-Aria compliments the specifications of the LSRII. This approach allows researchers to migrate
experiments optimized on the analytic LSRII to the Cytek-Aria for cell sorting. Acquiring the Aurora analytic
cytometer allowed users to capitalize on the cutting-edge technology of analytic cytometry with complexity
comparable to the CyTOF (Mass Spectometry, but in a far more economical platform). The key features of the
Bigfoot include: jet-in-air sorting; built-in, certified bio-containment; and is the only instrument with both
“conventional” and “spectral” detection modes. This machine would allow the dovetailing of the analytic and
sorting functionalities and reproduce the specifications of the facility's current sorters. It will advance state-of-
the-art cytometry to users and provide much-needed support in maintaining the current service levels.

Public health relevance
FACS based cell sorting is an essential tool used in many NIH funded laboratories to carry out their research. It has a wide range of research applications, and within Tufts University, it is currently used in areas such as immunology, microbiology, infectious diseases, ophthalmology, newborn medicine, and others. Replacing the current obsolete cell sorter with the Bigfoot Spectral Cell Sorter (ThermoFisher Scientific) will guarantee the continuity of service at the Tufts Laser Cytometry core, the only such service provider at Tufts.